PREVENTION OF LEFT VENTRICULAR HYPERTROPHY AND RENAL FAILURE IN PKD

This study will determine which level of blood pressure best reverses left ventricular hypertrophy, renal failure and improves naturiesis in hypertensive patients.